Research Project 4:Investigating and targeting the glucocorticoid receptor (GR) in enzalutamide- and abiraterone-resistant prostate cancer

The androgen receptor (AR)-directed agents enzalutamide and abiraterone acetate are standard first-line therapies for the treatment of patients with metastatic castration-resistant prostate cancer (CRPC). These agents are generally well tolerated and effective at delaying disease progression, prolonging survival, and improving quality of life, but both drugs have limited durations of effectiveness. Patients with refractory disease typically have poor responses to subsequent AR-targeted agents, and there is currently no predictive biomarker that aids in the selection of a second-line therapy. Our group and others have identified upregulation of the glucocorticoid receptor (GR) as one mechanism of resistance to enzalutamide and abiraterone acetate. Our findings suggest that 1) GR may be a biomarker that can predict whether a patient will respond to enzalutamide or abiraterone and 2) blocking GR upregulation in enzalutamide- and abiraterone-resistant patients could result in tumor responses. In preliminary data, we show that isoforms of GR with variable N-termini can be expressed in metastatic CRPC, including one called GRαC that has increased capacity to promote enzalutamide resistance and is detectable in some patient-derived organoid cultures. It will be necessary to characterize GRαC and other GR isoforms in order to develop GR as a biomarker and a therapeutic target. Using a laboratory model of enzalutamide resistance, we have also found that GR expression is epigenetically modulated, and that treatment with an inhibitor of the BET family of proteins suppresses GR expression and restores enzalutamide sensitivity. Expanding on these findings, we will leverage our group’s laboratory and clinical expertise to 1) investigate the role of GR isoforms in resistance to enzalutamide, 2) define the broader effects of BET inhibition across a range of preclinical models of prostate cancer, and 3) investigate the activity of a novel BET inhibitor in men with metastatic CRPC whose disease has progressed on enzalutamide or abiraterone acetate.

Public health relevance
Enzalutamide and abiraterone acetate are standard first-line treatments for men with prostate cancer that has spread and continued to grow despite injections that lower the level of the male hormone testosterone. While enzalutamide and abiraterone acetate are effective for most patients, tumors eventually become resistant and begin to grow again. In the laboratory, we have found that some tumors become resistant by increasing the level of a protein called GR, and we also found that an investigational drug called a BET inhibitor reduces GR levels in these tumors and causes them to shrink. This project will investigate whether different types of GR promote resistance to enzalutamide, how BET inhibitors work in prostate cancer cells, and whether BET inhibitors can shrink tumors in patients with advanced prostate cancer whose disease progressed on enzalutamide and abiraterone acetate.